Novel roles by glutamatergic receptors in the synaptic effects of beta amyloid

DESCRIPTION (provided by applicant): Novel roles by glutamatergic receptors in the synaptic effects of beta amyloid Long-term potentiation and depression (LTP and LTD) are promising and widely studied examples of vertebrate synaptic plasticity in which there is a persistent synaptic enhancement or decrement, respectively, seen following brief conditioning periods of synaptic activity. In both these forms of plasticity, which are leading models of memory, NMDA receptors (-Rs) and AMPA receptors (-Rs) at synapses play key and distinct roles. The general aim of this grant has been to examine the subcellular signaling controlling LTP and LTD. Recently, we have found that beta amyloid (Aβ), a peptide strongly implicated as a causative agent in Alzheimer's disease, has pronounced effects on AMPA-R trafficking requiring a novel form of NMDA-R signaling. In this grant period, we will examine the different roles played by NMDA-Rs and AMPA-Rs and their associated proteins in the effects of Aβ on synapses. Our preliminary studies show that a non-ionic form of NMDA-R signaling as well as a specific subunit of AMPA-Rs are required for Aβ to modify excitatory synapses. Here we will examine these findings using several complementing methodologies including molecular biology, electrophysiology, and two-photon laser scanning microscopy. These studies will use heterologous cell lines, organotypic rat hippocampal slices and genetically modified mice. The results of these studies will elucidate the mechanisms underlying Alzheimer's disease as well as provide potentially efficacious treatment strategies. The specific aims are to determine: Specific Aim 1: The role played by NMDA-Rs and associated molecules in Aβ-induced synaptic depression Specific Aim 2: The role played by AMPA-Rs and associated molecules in Aβ-induced synaptic depression

Public health relevance
PUBLIC HEALTH RELEVANCE: Synapses, the sites of communication between nerve cells, are thought to be early targets of damage in Alzheimer's disease. Abnormally high levels of the peptide A� is thought to be causative in the disease. Understanding such a process may provide insight into treatment of Alzheimer's disease.